2014 ASN Advance in Research Conference

DESCRIPTION (provided by applicant): The annual meeting of the American Society of Nephrology (ASN) is the largest gathering in the world of clinical and basic scientists working on the kidney. During the first two days of Kidney Week, the ASN sponsors a series of intensive symposia including a 2-day Advances in Research symposium for clinician investigators, graduate students, postdoctoral fellows, early- to mid-career academicians, practicing physicians and allied health care professionals. The subject area of this symposium is reviewed thoroughly by the ASN's Post- Graduate Education (PGE) Committee and reflects important and time-sensitive areas of clinical and translational investigation with important clinical and public health implications for the management of kidney diseases and their related comorbidities and complications. The 2014 ASN Advances in Research Conference entitled, Building a Kidney: From Stem Cells to Function, scheduled for November 11-12, 2014 in Philadelphia, PA. The conference will explore concepts, innovations and best practices in tissue regeneration as it relates to the kidney. The purpose of this grant application is to request funds for postdoctoral fellow and graduate student travel awards so that ASN members at early stages of their careers can attend this conference prior to the 2014 ASN annual meeting in Philadelphia, PA.

Public health relevance
PUBLIC HEALTH RELEVANCE: This conference focuses on exploring concepts, innovations, and best practices in tissue regeneration as it relates to the kidney. Over two days, the expert faculty address engineering new kidney tissue based on the embryo as well as kidney repair and regeneration using cellular approaches. In the closing session, a panel discussion with participation from faculty and attendees outlines the current successes, challenges, and next steps. This course will stimulate new areas of study and collaborations among the attendees-erasing the physical and social boundaries that exist between scientists in different field of stud (e.g., stem cell biologists and bioengineer), and directing future studies so that building a kidne becomes a reality. This course brings together leading scientists, physician-scientists, clinicians and trainees from diverse areas with common interests in tissue regeneration.